Targeted Delivery of Cas9 to Lung Epithelial Cells using Enveloped Delivery Vehicles

PROJECT SUMMARY/ABSTRACT
The rapid development of genome editing tools has outpaced the ability to deliver these molecules specifically
to diseased cells in human patients. A major bottleneck in expanding in vivo applications of genome editing is
the lack of targeted, cell-specific delivery vehicles. Current state-of-the-art methods rely on lipid nanoparticles or
adeno-associated viruses for delivery. Although these methods can broadly edit tissues in the lung, they lack
specificity for diseased cells and pose risks of off-target effects. The safe and effective use of CRISPR-Cas
enzymes as treatments for pulmonary and infectious diseases requires the development of cell-type specific
delivery vehicles in the lung.
In this proposal, we will engineer Enveloped Delivery Vehicles (EDVs) to deliver Cas9 ribonucleoproteins to lung
epithelial cells. We will target lung epithelial cells due to their involvement in pulmonary diseases such as
surfactant disorders. EDVs are bioengineered virus-like particles derived from lentivirus that package Cas9
proteins. We have previously shown that EDVs can specially edit T-cells in culture and in mice by displaying
antibodies on their surface.
Building on our laboratory’s expertise with virus-like particles and CRISPR-Cas9 mechanistic biology, we will
focus on determining the mechanisms of Cas9 packaging that will enable EDV targeting to lung epithelial cells.
Our first aim is to determine how EDVs encapsulate Cas9 and its guide RNA. Preliminary data from experiments
using chemical inhibitors and genetic deletions have begun to reveal which viral components of EDVs are
necessary to mediate genome editing. Non-essential components will be eliminated to optimize EDV design and
enhance editing efficiency. Concurrently, our second aim is to identify antibody fragments that facilitate the entry
of EDVs into lung epithelial cells. Antibody fragments displayed on the surface of EDVs will target epitopes
commonly utilized by respiratory viruses on epithelial cells. We will evaluate the ability of these antibodies to
mediate precise cell entry of EDVs and facilitate genome editing. These two aims are independent but
complementary. The outcomes of each will provide valuable insights into the internal and external design
elements necessary for targeting and editing lung epithelial cells.
While genome editing enzymes hold the potential to treat potentially all genetic diseases, strategies to deliver
these components beyond the liver and blood are needed to realize this potential for patients. We anticipate that
the mechanistic insights gained from this proposal will guide future efforts to target delivery vehicles to new cell
types of interest.

Public health relevance
PROJECT NARRATIVE CRISPR-Cas genome editing enzymes have the potential to treat infectious and pulmonary diseases in the lung but delivering them specifically to diseased cells is a challenge. This proposal will determine how lentivirus-like particles package and deliver Cas9 with its guide RNA to specific cell types and how this mechanism can be harnessed for genome editing of lung epithelia, a tissue implicated in many diseases. The development of a specific delivery method for CRISPR-Cas editing components in lung epithelial cells will be transformative for genetically treating lung diseases.